Maternal-Fetal Medicine Unit (MFMU) Network Clinical Centers

The purpose of this proposal is to demonstrate the capabilities of the University of Pittsburgh to
continue to participate as a clinical site in the Eunice Kennedy Shriver NICHD Maternal-Fetal
Medicine Units Network (MFMUN). We are particularly well suited to be a clinical site in this
Network because of our delivery volume; clinical research infrastructure and track record; basic
and translational experience and expertise; and specialized resources that we can bring to the
Network. Approximately 10,000 women deliver per year at Magee-Womens Hospital, and 75%
of these women initiate prenatal care in our system at < 14 weeks. Our site, a large volume
delivery-perinatal center under a unified administrative structure, is ideal for participation in the
MFMU Network. Through our extensive research infrastructure, we have successfully enrolled
women as early as the first trimester, followed them longitudinally through pregnancy to
delivery, conducted randomized clinical interventions, and have performed serial collection and
processing of biological samples and ultrasound data. We also have demonstrated success in
longitudinal postnatal maternal and neonatal follow-up. The demography of our population
allows us to contribute uniquely to the study of preterm birth and other adverse pregnancy
outcomes. Additionally, our site brings unique content and technical expertise in clinical
obstetrics, fetal imaging, genomics and proteomics, placental pathology, and epidemiology. All
these areas are represented among our faculty, and we have a long and successful history of
research collaboration, within our institution and via multicenter studies. In this application, we
aim to: 1. To describe our experience, infrastructure, and track record of participation in single-
center and multicenter studies of adverse pregnancy outcomes 2. To demonstrate our ability to
enroll a diverse patient population and demonstrate our ability to continue to enroll and provide
maternal and newborn follow-up to subjects for ongoing and new MFMU studies 3. To delineate
our unique suitability in terms of technical and multidisciplinary content expertise to
address the objectives of the MFMU Network.

Public health relevance
The purpose of this proposal is to summarize the resources at Magee-Womens Hospital and the University of Pittsburgh and to demonstrate how we will continue to contribute meaningfully to the mission and objectives of the NICHD-sponsored Maternal-Fetal Medicine Units Network. We are enthusiastic about contributing to the success of the MFMU Network and its continued pre- eminence in clinical research.